Auditory Circuits for Interpreting Vocal Communication Signals

Project Summary/Abstract
Interpreting vocalizations in communication, such as human speech, necessitates the segmentation of
the sound stream into meaningful units and the identification of their corresponding meanings. Although
research on the neural basis of human speech perception has demonstrated the entrainment of neural activity
in auditory areas by the speech sound envelope, the specific mechanisms underlying neural segmentation and
its facilitation of the identification task remain poorly understood. Furthermore, while categorical neural
responses to sound classes have been observed, the computational processes and representations enabling
the categorization of a complete communication system, for example, encompassing all phonemes in a human
language, remain largely unexplored. To bridge these gaps in knowledge, we have developed a songbird
model that promises to shed light on these fundamental processes. In previous research, we made a
significant breakthrough by uncovering a combinatorial neural code in the avian auditory cortex responsible for
identifying all call types within a bird's repertoire. Building upon this discovery, our study aims to investigate
how the auditory system generates this ensemble code for identification while concurrently segmenting the
sound stream into meaningful segments. In Aim 1, we will examine the neural basis of segmentation using
animals actively engaged in listening tasks or natural communication scenarios, allowing us to study the impact
of attention on this process. The human vocal communication system also relies on the ability to learn and
identify novel sound categories, such as new words or the distinct voice of a speaker. Fascinatingly, our
research has demonstrated that songbirds possess a similar capacity to rapidly recognize the voice
characteristics of numerous conspecifics. Accomplishing this voice identity task necessitates the formation of
auditory memories. In Aim 2, we will explore the neural mechanisms underlying the identification task for these
learned vocal categories. Our investigations will provide valuable insights into the roles played by distinct
circuits within the auditory cortex in processing semantics and voice. This knowledge is critical for
comprehending how dysfunctional auditory processing in multiple mental disorders as well as aging affects
speech recognition and, subsequently, other cognitive abilities.

Public health relevance
Project Narrative We will study how neural circuits in the auditory cortex categorize vocalizations into meaningful units. This research is critical for understanding how the brain performs the sound to meaning transformation needed for speech perception. It will also be useful for optimizing the design of the next generation of hearing aids and cochlear implants and for understanding the causes of deficits in speech comprehension commonly found in autism and other mental disorders.